Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core (AC) is the unit responsible for overall governance and leadership of the UCD ADC as well as a resource for developing new research initiatives, new training initiatives and representing the UCD ADC within and outside the UC Davis community. In addition, the AC interacts closely with the UCD School of Medicine (SOM) Leadership and the Program Officers of the NIA Alzheimer's Disease Centers program to further the goals of research, training and education in accordance with their scientific and academic mandates. In pursuit of these general goals, the Administrative core emphasizes four major themes that encompass 1) supporting scientific innovation, 2) leveraging available resources through integration of research effort and pursuit of research funding, 3) program growth through seeking local, national and international collaborations and initiation of new programs, and, finally, 4) pursuit of funding sources for training of junior scientists so as to expand and provide continuity for our program of research on aging, Alzheimer's disease and associated dementias. Our success over the last four years has positioned the AC to respond further to the new requirements of the RFA as well as the challenges and opportunities presented by today's scientific research environment. As such the AC will continue to provide strong leadership along with the infrastructure and the administrative support needed to meld the various Cores and geographically dispersed units of the UCD ADC into a true, coherent Center. At the UCD ADC, this is accomplished primarily through strong leadership and an effective management structure that emphasizes clear communication and can establish workable policies and procedures to optimize effort toward successful completion of the aims and evolving needs of the UCD ADC.

Public health relevance
RELEVANCE (See instructions): The success of the UCD ADC depends on strong leadership and an effective management structure. The Administrative Core is relevant to the success of the Center through the guidance, leadership and effective organization that it brings to integrate and coordinate the efforts of the UCD ADC to maximize utilization of research resources, scientific productivity, education and the training of junior scientists.